The Effects of Muscle Fatigability on Gait Instability in Aging and Age-Related Falls Risk

PROJECT SUMMARY
Falls are a severe societal issue with vast physical and economic consequences. As we age, there are a variety of
factors that are associated with an increased falls risk such as declines in sensor, motor, and cognitive-motor
acuity. These changes may affect how we compensate for being in a fatigued state to better navigate dynamic
walking challenges due to the additional risks that they put older adults at for falls. The overarching scientific
premise of this fellowship proposal is that local muscle fatigability compromises the neuromuscular control of
walking balance and importunately precipitates gait instability in a direction-dependent and context-specific
ways in older adults. This project will recruit 30 young adults, 30 older adult non-fallers, and 30 older adult
fallers to participate in two sessions: one designed to objectively target the local fatigability of muscles that
regulate sagittal plane motion and stability and another designed to objectively target the local fatigability of
muscles that regulate coronal plane motion and stability. This project strategically combines sophisticated
motion capture and electromyographic time-frequency analyses with an innovative suite of walking balance
perturbations designed to emulate real-world balance challenges to identify novel mechanistic causes for
increased falls risk. This research study will be the first to establish the mechanisms behind fatigues effect on
walking stability through the usage of directional local muscle fatigability and a comprehensive and task specific
collection of walking balance perturbations integrated with musculoskeletal modeling and simulations. This area
of mechanistic and hypothesis-driven research has been severely understudied, but has significant and
immediate potential to inform novel advances in diagnostics, rehabilitation, mobile monitoring, and wearable
assistive technologies to mitigate falls.

Public health relevance
RELEVANCE TO PUBLIC HEALTH This study will establish the cause-and-effect relationship of local muscle fatigability on walking stability through a combination of sophisticated motion capture and electromyographic time-frequency analyses with an innovative suite of walking balance perturbations designed to emulate real-world balance challenges. Through our approach, we will address several gaps that are currently impeding the field to have an immediate impact on our understanding of the directional dependence of fatigability on walking stability and on the influence of age and falls risk on the effects of local muscle fatigability. This work will also serve as a benchmark for underlying changes, in later research, neurological injury and neurodegenerative disease.